IDENTIFICATION OF PHOSPHORYLATION SITES ON GLUTAMATE RECEPTOR MGLUR5

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. we are using hypothesis-driven mass spectrometry to identify novel phosphorylation sites on the metabotropic glutamate receptor, mGluR5. Mutants of the specific sites of phopshorylation will be constructed to obtain information about the roles of these sites on the function of the receptor.